Planar Polarity Mechanisms in Mammalian Inner Ear Development

Project Summary:
In the vestibular system of the inner ear, motion is detected via the mechanical deflection of a bundle of
stereocilia located at the top of sensory receptor hair cells. The bundle is morphologically and physiologically
polarized because only movements of the bundle towards a lone kinocilium positioned at one side of the apical
cell surface are able to produce excitatory responses to acceleration or gravity. Thus, the range of motion that
can be detected by an individual hair cell is determined by the polarized orientation of the stereociliary bundle.
The utricle and saccule contain thousands of vestibular hair cells that detect linear accelerations which are
divided between two groups that have opposite stereociliary bundle orientations and therefore respond to motion
in opposite directions. These two groups of hair cells meet at a cellular junction that anatomically divides the
utricle and saccule called the Line of Polarity Reversal (LPR).
Our goal is to identify the cellular and molecular mechanisms that direct the development of planar polarity and
the LPR, and underlie the formation of a sensory representation of gravity and acceleration in the mouse utricle
and saccule. This will be addressed throughout the course of the project using a combination of knockout and
transgenic mouse models, molecular genetic approaches to evaluate the transcriptional regulation of an
essential regulatory kinase called STK32A, and biochemical and proteomics approaches to identify STK32A
substrates. Specifically, we will test the hypothesis that patterns of Stk32a gene expression are determined by
the transcription factor EMX2, and that STK32A guides stereociliary bundle orientation in hair cells that do not
express EMX2. STK32A is a dark kinase with previously unknown function, which my lab has recently shown to
be necessary and sufficient to determine stereociliary bundle orientation. This effort is significant and innovative
because it introduces post-translational modification by kinase signaling as a new regulatory mechanism guiding
hair cell planar polarity, and because it focuses on the EMX2-negative hair cells that were previously excluded
from studies, including my own, that focused specifically on EMX2. Although directed towards the development
of vestibular planar polarity, we anticipate that this research will impact our understanding of auditory planar
polarity as well as other organ systems that rely upon cellular polarization for growth or function.

Public health relevance
Project Narrative: The polarized development and organization of stereociliary bundles on sensory hair cells of the inner ear underlies the detection of sound and motion, and vestibular hair cell function is important for maintaining balance and posture. This project is designed to determine how stereociliary bundle polarity is established during inner ear development and how hair cells are organized within the utricle and saccule so that that individual sensory organs can detect linear accelerations across a range of motion. By understanding the developmental processes building the peripheral vestibular system we can understand how those processes are disrupted in disease states that cause balance disorders and falls, and identity targets for therapeutic intervention.